Post-translational Regulation of Opioid and Cannabinoid Receptors.

Project Summary This is an application for a Research Supplement to Promote Diversity in Health-Related Research (PA-18-586). The Parent R37 Project associated with this application is entitled “Post- translational Regulation of Opioid and Cannabinoid Receptors” supported by NIDA (R37DA08863-23). Seshat Mack is the diversity candidate. She is a US citizen of African- American descent and is currently an MD/PhD graduate student at Icahn School of Medicine at Mount Sinai, New York. The main goal of this study is the characterization of a newly deorphanized striatal neuropeptide receptor involved in modulating rewarding behaviors.

Public health relevance
Project Narrative These studies are likely to open new avenues of research relating to neuroendocrine regulation of reward- related disorders. In addition to providing essential information about signaling by this novel neuropeptide- receptor system, these studies describe compounds with great research and/or therapeutic potential.